Structure-based mechanism of the augmin complex in promoting branching microtubule nucleation and spindle assembly

Project Summary: Rapid and organized assembly of meiotic and mitotic spindles is essential for
ensuring proper segregation of chromosomes during cell division. A majority of spindle microtubules
are generated via branching microtubule nucleation. In this microtubule nucleation pathway, new
microtubules are nucleated from pre-existing microtubules in shallow angles, which causes exponential
amplification of microtubules. Augmin, a large hetero-octameric complex conserved throughout
eukaryotes, is essential for branching microtubule nucleation. It is required both to recruit nucleation
factors to the pre-existing microtubule and, by orienting the nascent microtubule at an acute angle to
the mother, to ensure that spindle polarity is maintained. Yet how augmin carries out these two functions
remains poorly understood, both because we lack a complete picture of augmin's direct binding
partners and because we have no high resolution structural information about the augmin complex. I
will use a combination of single particle cryo-electron microscopy, reconstitution experiments using
purified proteins, and ex vivo Xenopus laevis meiotic egg extract assays to determine how the augmin
complex enables branching microtubule nucleation and establishes correct microtubule branching
geometry in the spindle. In addition to revealing the mechanism that underlies this key aspect of spindle
formation, insight into the structure and function of the augmin complex will also provide us with a
foundation to understand how other complex microtubule nucleation sites are organized within the cell.
In addition to giving me the biological background I need to pursue my ultimate scientific interest of
how the microtubule cytoskeleton cooperates with vesicle trafficking, this proposed research plan will
also train me in two key technical areas that I will need to establish my own independent research
group. The first of these is a TIRF-based assay to study microtubule nucleation at the single molecule
level using Xenopus laevis meiotic egg extract. This ex vivo system is an incredibly powerful tool that
allows precise depletion or replacement of protein components to quantitatively determine their
contribution to microtubule nucleation, bridging the gap between bottom-up reconstitution approaches
and live-cell imaging. One of my primary motivations for working with Dr. Petry was to be trained in this
method. The second technique, which I will use extensively throughout this proposal, is single particle
cryo-electron microscopy, especially in solving the structures of extended and dynamic molecules. In
learning this technique, I will benefit from the mentorship of my co-sponsor Dr. Nieng Yan and the
cutting-edge vibrant structural biology community at Princeton as a whole. Finally, I will learn from Dr.
Petry and Dr. Yan how to successfully lead a research group that fearlessly leverages a broad range
of techniques and disciplines to answer critical scientific questions.

Public health relevance
Project Narrative Microtubules of the mitotic spindle orchestrate proper segregation of chromosomes during cell division. This work will reveal how the augmin complex generates spindle microtubules during mitosis. By determining the structure of the augmin complex, we will better understand not only mitosis, a critical event in the lifecycle of the cell, but also how spindle assembly is misregulated in many cancers to cause uncontrolled cell division.